Asynchronous Open Online Course Addressing Structural Racism and Discrimination to Reduce Disparities

Project Summary
The goal of this project is to develop an accessible and open online asynchronous Structural
Racism course on a scalable platform for a diverse population of trainees within the biomedical
research space. We build on our team's decades of professional experience and engagement in
interdisciplinary scholarship related to curriculum/training development, structural racism,
technology/platform development, and working towards increasing diversity, recruitment, and
persistence of underrepresented minorities within the biomedical research workforce. We
propose developing training modules that address and mitigate structural racism and
discrimination, piloting these modules, and then make available nationwide as an asynchronous
open online course. Partnership with the National Research Mentoring Network (NRMN) will
enable the course's rapid development, refinement, and pilot testing. We will develop the
Structural Racism course and disseminate widely using our national learning and mentoring
platform (MyNRMN) that would facilitate inclusive, accessible, and equitable environments that
ultimately cater to the recruitment and persistence of individuals within the biomedical research
space. Hosting and delivery of the course on the MyNRMN platform brings both the scalability (to
thousands of learners) and accessibility (open/free and web-based) for widespread impact by
offering an on-demand training opportunity to individuals across disciplines and career stages
within the biomedical research workforce. The dynamic, asynchronous nature of the course is
intended to be flexible for adaptation by NIH-funded training programs, higher education
institutions, and professional societies. We will pilot test the structural racism course with NRMN
students and faculty (from across the nation) to evaluate the course and curriculum and determine
changes that need to be implemented to prepare the course for national rollout. Our multifaceted
dissemination plan will target diverse individuals across disciplines and career levels. The specific
aims are: Aim 1: Develop a structural racism course curriculum and build the course as an
asynchronous open online course. Aim 2: Pilot test and revise the asynchronous open online
course that addresses structural racism and discrimination with individuals from all career stages.
Aim 3: Disseminate the asynchronous open online course nationwide through evidence-based
strategies. The expected outcomes from this project will be a freely available, accessible, and
online Structural Racism course that addresses structural racism and discrimination.

Public health relevance
Project Narrative The goal of the Asynchronous Open Online Course Addressing Structural Racism and Discrimination to Reduce Disparities project is to provide nationwide training modules that focus on addressing and mitigating structural racism and discrimination. We will develop an online Structural Racism course and disseminate widely using our national learning and mentoring platform that would facilitate inclusive, accessible, and equitable environments that ultimately cater to the recruitment and persistence of individuals within the biomedical research space.